Administrative Core

PROJECT ABSTRACT: ADMINISTRATIVE CORE
The primary objective of the Administrative Core (AC) is to serve as the leadership, coordination and
communication hub for the Dartmouth Learning Health System (LHS) Embedded Scientist Training and
Research (E-STaR) Center. The proposed Center’s focus on developing future LHS leaders in PCOR/CER is
grounded in a coproduction LHS, which explicitly recognizes and prioritizes the collective expertise of patients,
their care partners, clinical teams, health system operations and quality improvement leaders, and the larger
communities in which we live and work.
The AC will support the Center by establishing and carrying out processes for recruitment, selection and
retention of a diverse group of LHS scientists. The AC will support the Research Education Core’s (REC)
activities, which include the development, implementation and tracking of 18-month tailored training plans
designed to meet each scientists needs in PCOR/CER and LHS competencies. Scientist’s experiential learning
will involve conducting a PCOR/CER project that will be guided and supported by the Research and Data
Analysis Core (RDAC) from design through dissemination of evidence-based findings, including integration into
the LHS.
The AC specific aims are:
Aim 1: To provide overall leadership for the Dartmouth LHS E-STaR Center by establishing processes for: a)
governance and management, b) scientist recruitment and project selection, and c) ensuring effective
community engagement with community and stakeholder partners through collaboration with the DH Center for
Advancing Rural Health Equity.
Aim 2: To promote effective communication across the Center and with regional and national LHS communities
through regular communication via: a) a Center web platform, b) regular meeting and reporting schedules, and
c) a LHS Learning Collaborative with a quarterly national webinar addressing issues of healthcare access for
rural populations.
Aim 3: To measure the Center’s ongoing progress through regular evaluation and reporting of metrics for
success across each of the Center’s components and the Center’s overall impact on increasing timely access
to healthcare.
Through the AC, the Center PIs and research administrative staff will work together to create an inclusive
environment of trust and shared accountability. Collectively, all involved will coproduce evidence-based
solutions for advancing rural health equity while training the next generation of LHS scientists in PCOR/CER
methodologies and LHS competencies.